Reversing Microglial Inflammarafts and Mitochondrial Dysfunction in Alzheimer's Disease

Project Summary
Neuroinflammation is a major factor in the progression of Alzheimer's disease (AD). Inflammatory brain microglia
are characterized by altered cholesterol and lipid metabolism. Cholesterol and many receptors governing
inflammatory responses colocalize in the ordered membrane microdomains often designated as lipid rafts. Upon
activation, lipid raft resident and recruited molecules assemble and initiate signaling cascades leading to
inflammation. We have identified the apoA-I binding protein (AIBP, encoded by the APOA1BP gene) as a key
regulator of cellular cholesterol metabolism, which can selectively target lipid rafts in inflammatory cells
(inflammarafts) via its binding to TLR4. While extracellular AIBP regulates cholesterol depletion from the plasma
membrane and controls lipid rafts, intracellular AIBP localizes to mitochondria, facilitates mitophagy and helps
maintain normal mitochondrial function and control oxidative stress. Apoa1bp-/- APP/PS1 mice present more
amyloid beta (Aβ) plaques, an exacerbated dysfunctional microglia phenotype and show increases in cell death
when compared to APP/PS1 mice. Mitochondria in AIBP-deficient microglia are morphologically distorted, with
a characteristic hyper-branched and cupped shape, typically seen following oxidative stress. The AAV-mediated
expression of a secreted form of AIBP in the brain of Apoa1bp-/- APP/PS1 mice restored the homeostatic
microglia morphology. The goal of this proposal is to delineate mechanisms governing protective effects of AIBP
in the AD brain, focusing on microglial lipid rafts and on mitochondrial dysfunction. Specifically, in Aim 1 we
propose to test the hypothesis that extracellular AIBP reverses pathological lipid rafts in microglia to reduce
neuroinflammation and protect against neurodegeneration in a mouse model of AD. We have identified a TLR4-
binding domain in the AIBP molecule and demonstrated that an AIBP(ΔTLR4) variant, which does not bind TLR4,
cannot reverse lipid raft alterations. Using AAV delivery, we plan to restore expression of secreted variants of
AIBP in the brain of Apoa1bp-/- APP/PS1 mice and expect that AIBP(wt) but not AIBP(ΔTLR4) will lessen
neuroinflammation, the Aβ plaque burden and accumulation of phospho-tau. We also expect improvements in
memory and learning. In Aim 2, we will be testing the hypothesis that intracellular AIBP protects mitochondrial
dynamics and function in a mouse model of AD. Mitochondria are the major sites displaying concentration of
intracellular AIBP, and preliminary studies suggest AIBP involvement in control of mitochondrial function,
mitophagy and oxidative stress. Methods will include correlated light microscopy and 3D EM across scales,
leveraging advances in serial blockface scanning EM and EM tomography, along with correlated measures of
bioenergetics by Seahorse. To test relevance of the proposed mechanisms to human AD, in Aim 3 we will
characterize AIBP-related markers of lipid rafts and mitochondrial dysfunction in postmortem and biopsy brain
sections from AD subjects.

Public health relevance
Narrative Chronic activation of brain microglial cells and attendant neuroinflammation are major factors in the progression of Alzheimer's disease. We identified novel mechanisms that protect against microglial inflammatory hyperactivation and mitochondrial disfunction, resulting in reduced accumulation of amyloid beta plaques and neuronal cell death. These studies may suggest new therapeutic approaches to treatment of Alzheimer's disease.